The Role and Function of a Novel Signature Gene in BCR::ABL1 (Ph) B-cell Acute Lymphoblastic Leukemia

PROJECT SUMMARY
Philadelphia chromosome (Ph)-positive and Ph-like B-cell acute lymphoblastic leukemia (B-ALL) are high-risk
leukemia subtypes with poor long-term survival rates. Despite advances in treatment, patients with these
subtypes continue to have survival rates below 50%. Our research aims to address this urgent need by
focusing on a novel hallmark gene, AL021978.1 (hereafter named A978), which is identified as the most
significantly overexpressed gene in Ph/Ph-like B-ALL. Our preliminary data indicate that A978 encodes a short
protein located in mitochondria, promoting leukemic cell proliferation, and contributing to resistance against
tyrosine kinase inhibitors (TKIs).
The long-term objective of this project is to improve treatment outcomes for patients with Ph/Ph-like B-ALL.
Our specific aims are: 1) to determine the biological effects of A978 in leukemic cells; 2) to study the effects
and functions of A978 in mitochondria and metabolic activities; and 3) to evaluate the therapeutic impact of
pharmacologically inhibiting A978 in Ph B-ALL.
To achieve these aims, we will use a combination of in vitro and in vivo models, including B-ALL cell lines and
patient-derived xenograft models. We will employ a variety of techniques, such as RNA sequencing (RNA-
seq), single-cell RNA-seq, BioID and mass spectrometry, and metabolomic profiling, to explore the molecular
functions and biological pathways regulated by A978. Additionally, we will develop and evaluate a therapeutic
strategy using a CpG-conjugated small interfering RNA to specifically silence A978 expression in leukemic
cells.
The significance of this project lies in its potential to uncover new mechanisms driving the proliferation and
progression of high-risk B-ALL subtypes. By targeting A978, we aim to develop novel therapeutic strategies
that can be combined with existing treatments to enhance their efficacy. This research is expected to largely
advance our understanding of Ph/Ph-like B-ALL and contribute to the development of more effective
treatments, ultimately improving survival rates for patients with these high-risk leukemias.

Public health relevance
Project Narrative Philadelphia chromosome (Ph)-positive and Ph-like B-cell acute lymphoblastic leukemia are high-risk leukemia subtypes with poor long-term survival rates. Our research focuses on a novel hallmark gene, AL021978.1 (A978), which we have identified as a key driver in these leukemias. We aim to understand how A978 contributes to leukemic cell proliferation and explore therapeutic strategies to target A978, potentially improving outcomes for patients with these high-risk leukemia subtypes.